Host- and pathogen-specific risk factors for post-tuberculosis lung disease among people successfully treated for TB in Lima, Peru: Beat-PTLD

Project Summary
An estimated 10 million individuals develop TB disease each year, most of whom live in low-and
middle- income countries. In addition to the morbidity and mortality associated with the disease
episode itself, TB leads to long-term compromise of lung function and chronic respiratory
disability even after successful TB treatment. Although preventive therapy and early TB
diagnosis and treatment likely reduce this risk, many tuberculosis patients experience residual
lung pathology, with studies demonstrating substantial pulmonary impairment due to obstructive
lung disease, restriction, bronchiectasis, and pulmonary hypertension, as well as secondary
non-tuberculosis lung infections including aspergillosis. A modeling exercise estimated that
among the 122 million disability adjusted life years (DALYs) lost due to TB in 2019, 55 million
(47%) resulted from post-TB lung disease (PTLD). Despite the enormous global burden of lung
impairment following successful TB treatment, major knowledge gaps in PTLD hinder the
identification of high-risk individuals and the development and testing of interventions to mitigate
TB's long-term impact on lung function and overall health. These include lack of knowledge of
the frequency of PTLD and its subtypes, of the risk factors for PTLD, and of the most efficient
ways to screen for the disease. Here we propose to leverage an existing NIH-funded cohort
study to evaluate 1000 successfully treated TB patients 2-3 years after their initial TB diagnosis
—and 291 community controls—in Lima, Peru for the occurrence of lung impairment. We will
use spirometry, high resolution chest CT, and echocardiography to characterize PTLD
phenotypes in this cohort. We will estimate the relative risks of putative determinants of PTLD
that were measured at the time of TB diagnosis and develop a predictive model that could be
used to triage TB patients at high risk for PTLD for interventions. We will also assess the
contributions of host and bacterial genetic variation in the etiology of the disease. Finally, we will
assess the performance of a battery of functional assays, questionnaires, and biomarkers as
screening tests for PTLD. The successful completion of this study will allow us to estimate the
frequency of different types of PTLD among TB survivors, describe the host and bacterial
factors that lead to PTLD, and identify the tools that enable accurate assessment of the extent
of lung impairment.

Public health relevance
Project Narrative Many TB patients develop long-lasting pulmonary impairment or post-TB lung disease (PTLD) after successful treatment for their TB disease. To date, little is known about the frequency of PTLD and its various sub-types or the human and bacterial factors that contribute to it. We propose to leverage an ongoing study of TB patients recruited in Lima, Peru to measure the prevalence of PTLD, identify determinants of this disease, and develop tools to screen for it.